The impact of Aryl hydrocarbon receptor signaling on Toll like receptor-mediated inflammation

Project Summary/Abstract
The aryl hydrocarbon receptor (AhR) plays an important role in regulating immune responses and exposure to
AhR-activating compounds, including environmental toxicants such as dioxins may contribute to the
dysregulation of cytokines and the development of immune system disorders. The ligand-dependent activation
of AhR can promote differentiation of inflammatory T helper Th17 cells or lead to profound immunosuppression
and an increase of regulatory T cells. Significant gaps exist in our understanding of how the AhR regulates the
inter- and intracellular communication processes between dendritic cells (DC) and other immune cells on the
molecular level, which is of central importance to understanding both physiologic and pathophysiologic immune
reactions mediated through AhR. The overall goal of this proposal is to identify the functional role of the AhR and
its specific repressor (AhRR) interacting with Toll-like receptor (TLR) and NFkB signaling in controlling function
and differentiation of DC and T-cell activation. The reported dysregulation of TLR and NFkB signaling by AhR
ligands may be key steps in triggering immune system disorders. The transcriptional repressor of the AhR, the
AhRR is implemented in the AhR pathway, although much remains to be elucidated at the level of TLR and
NFkB signaling. In transgenic mice overexpressing AhRR we discovered that AhRR is critically involved in
regulation of dioxin-induced inflammatory gene expression as well as LPS-mediated inflammatory responses
and LPS shock. Thus, the AhRR Tg mice give us the opportunity to recognize how AhRR is involved in the
regulation of TLR-mediated responses and other parts of the immune system. Bone-marrow derived DC from
genetic mouse models as well as human DC, will be used to investigate how DC are regulated through ligand-
induced activation of the AhR and inflammatory signals via TLR/NFkB. A genome-wide identification of AhR/Rel
binding sites will be conducted and related to gene expression analysis. Mutants of binding sites will be
generated to validate whether a particular binding event is actually required to regulate the expression of target
genes. Protein-protein interaction studies will identify the specific interacting domains of AhR and Rel proteins
and provide insight into how these interactions impact the functional activity of each protein and the outcome of
AhR/NFkB crosstalk. A novel in vivo method to monitor immune responses noninvasively via Positron Emission
Tomography (immuno-PET) imaging will be used to ultimately show how AhR ligands modify TLR-mediated
recruitment and accumulation of DC, neutrophils, B cells, and T cells in vivo. This study can provide a definite
link and mechanism between the exposure to AhR activating compounds and the development of inflammatory
chronic diseases. Findings will allow for more clearly defined endpoints to assess the effects and toxicity of AhR
activating ligands including environmental pollutants. This study will also provide new concepts for future
innovative uses of AhR and AhRR as molecular targets for therapeutic applications in inflammation, infection,
and chronic diseases.

Public health relevance
Project Narrative The present study focuses on a novel concept of the function of aryl hydrocarbon receptor (AhR) and its repressor (AhRR) as environmental sensors modifying the immune response. This study investigates the interference of the AhR and AhRR with key regulators of cellular processes (Toll-like receptors and NFκB) in immune cells. The current study is critical in understanding the biological and pathological functions of the AhR and AhRR in the immune system and its role in immunological disorders like allergy, autoimmune and infectious diseases. This work will help to understand the mechanism how environmental toxicants disturb critical functions of the immune system and have an effect on human health.